MULTICHANNEL SYSTEM FOR BIOMAGNETIC APPLICATION

Applied Research Corporation proposes the development of a new generation of biomagnetic instrumentation based on Superconducting Quantum Interference Devices (SQUIDS's). More specifically, ARC will develop inexpensive, user friendly multichannel electronics for SQUID's signal conditioning and digitization. Together with the availability of liquid nitrogen SQUID's, this will permit development of reasonably inexpensive device (say less than $30,000) for 16 channels magnetocardiograph (MCG) or magnetoencephalograph (MEG). In Phase I, we will develop a 4 channel magnetocardiograph with excellent signal/noise ratio. Electronic readout (preamp and lock-in amplifier) will be miniaturized onboard; ADC and IEEE-488 bus will be included. In Phase II we will develop a 32 channel magnetoencephalograph with typical noiose.